An optogenetic-based control paradigm for neuromodulation of bladder function following spinal cord injury

PROJECT SUMMARY
More than 17,000 Americans suffer from spinal cord injuries every year, and many of these patients suffer from
lower urinary tract dysfunction. One of these bladder disorders is detrusor-sphincter dyssynergia, where the
detrusor muscle, which constricts to push urine out of the bladder, and the urethral sphincters, which relax to
allow urine to pass out the urethra, cannot coordinate their actions to produce a void. Electrical neuromodulation
technologies can be effective in improving symptoms of lower urinary tract dysfunction but due the complexity of
the circuit and neural systems involved these therapies are unable to initiate a coordinated voiding contraction
on-demand. To address these limitations, we plan to develop an optogenetic neuromodulatory approach to target
and independently control the two main neuronal systems (parasympathetic and somatic motor) that are integral
to the voiding reflex. Optogenetic neuromodulation involves genetically expressing optically activated proteins in
neurons to modulate their activity with light stimulus. Using this method, we plan to express excitatory opsins in
parasympathetic neurons innervating the detrusor by using promoter restricted expression and anatomically
limited viral delivery (Aim 1). Activation of these neurons leads to detrusor/bladder contractions. To inhibit tonic
urethral sphincter tone, we will use a similar approach to target the somatic motor neurons innervating the
external urethral sphincter with inhibitory opsins (Aim 2). Inhibition of these neurons leads to sphincter relaxation.
We will test the specificity of expression, potential off target effects, as well as the physiological effects of opsin
activation in naïve and in a rat model of spinal cord injury. Finally, we will develop a control paradigm to
coordinate activation of detrusor with urethral sphincter relaxation, to initiate coordinated and complete emptying
of the bladder (Aim 3). The proposed project will develop innovative neuromodulatory techniques to control
bladder function. Further development of refined and efficient neuromodulation techniques is the first step in
developing closed-loop therapies to treat bladder dysfunction associated with spinal cord injury. Additionally,
these techniques will have wide applicability in other fields of peripheral nervous system gene delivery and cell-
type specific neuromodulation. Advances in neuromodulation of bladder function will bring us closer to goal of
improving the lives of patients with spinal cord injury.

Public health relevance
PROJECT NARRATIVE An estimated 250,000 Americans are living with spinal cord injury and bladder dysfunction accompanies more than 80% off these injuries. The goal of this project is to develop a neuromodulation paradigm using optogenetic techniques to coordinate and restore bladder voiding in an animal model of spinal cord injury. The long-term goal of the project is to develop targeted closed loop therapies for the treatment of patient’s bladder disorders related to spinal cord injury.